Institute for Clinical and Translational Sciences

The goal of the ICTS Mentored Career Development (MCD) program is to provide scholars with a comprehensive and cutting-edge set of research tools and leadership skills designed to help them successfully navigate a career in translational research in these challenging times. Our MCD has been structured and configured based on areas of expertise here at UC Irvine, robust collaborations with CTSA partners across the network, remarkably generous institutional support, and a faculty that has demonstrated its willingness to join us in creating this exceptional program. The program highlights five critical features. 1) Integrated Leadership?We have purposefully combined the NRSA and MCD programs under one leadership umbrella to ensure productive interaction among all of our scholars and trainees, and efficiencies in using training resources. Our NRSA and MCD leaders are also intimately involved in the overall ICTS governance and organization so that virtually all aspects of scholars’ training and research are interwoven into the broader activities of our CTSA Hub. 2) Focused Flexible Accelerated Studies (FFASt)?FFASt is a new series of immersive-learning workshops designed to cover current issues in translational research. Learning opportunities are designed to shorten the formal didactic component of the training process without disrupting research productivity. Topics include: a) Implementing Team Science Best Practices, b) The Crisis of Reproducibility in Biomedical Research, c) Teachable Elements of Innovation in Biomedical Research, and c) What Every Biomedical Researcher Must Know About Community Outreach and Engagement. 3) Experiential Learning Opportunities (Real World Externships)?In collaboration with (and in the spirit of) UC Irvine’s recent successful application for an NIH BEST (Broadening Experiences in Scientific Training), scholars will have the opportunity to work in private sector CROs, drug and technology development companies, and in health and law issues in the Superior Courts of Orange County. 4) Outreach and Inclusion Excellence? Working with successful existing programs in our School of Medicine that target underrepresented minorities, scholars will teach and mentor students regarding careers in translational research. These efforts will help prepare promising individuals for successful careers in medicine and simultaneously enlarge our own candidate pool of future translational researchers. 5) Outstanding Mentorship?Learning from best practices across the CTSA Network, scholars will have the advantage of a well-trained mentorship team consisting of both experienced translational researchers and specialists in the scholar’s area of interest. The mentors and scholars undergo frequent evaluation with the goal of identifying and fixing problems in the scholar’s progress at the earliest stages. Finally, mentors and scholars will be rewarded in a number of ways, including: ICTS vouchers for research support; enhanced access and reduced recharge for informatics and statistical consultations; dedicated pilot/feasibility grants; and personal guidance in extramural grant preparation.

Public health relevance
Project Narrative Page 259 Contact PD/PI: COOPER, DAN M Inst-Career-Dev-001 (236) References 1. Jeffe DB, Andriole DA, Wathington HD, Tai RH. The emerging physician-scientist workforce: demographic, experiential, and attitudinal predictors of MD-PhD program enrollment. Acad.Med. 2014 Oct;89(10):1398-407. PMCID:PMC4175019 2. Ballios BG, Rosenblum ND. Challenges facing physician scientist trainees: a survey of trainees in Canada's largest undergraduate and postgraduate programs in a single centre. Clin.Invest.Med. 2014;37(5):E268-E283 3. Rhee C, Gohil S, Klompas M. Regulatory mandates for sepsis care--reasons for caution. N.Engl.J.Med. 2014 May 1;370(18):1673-6 4. Romanick M, Ng K, Lee G, Herbert M, Coller BS. The Rockefeller University Graduate Tracking Survey System. Clin.Transl.Sci. 2014 Nov 13; 5. Feldman MD, Steinauer JE, Khalili M, Huang L, Kahn JS, Lee KA, Creasman J, Brown JS. A mentor development program for clinical translational science faculty leads to sustained, improved confidence in mentoring skills. Clin.Transl.Sci. 2012 Aug;5(4):362-7. PMCID:PMC3582327 6. Johnson MO, Gandhi M. A mentor training program improves mentoring competency for researchers working with early-career investigators from underrepresented backgrounds. Adv.Health Sci.Educ.Theory.Pract. 2014 Oct 2; 7. Balakrishnan AD, Kiesler S, Cummings J, Zadeh R. Research team integration: What it is and why it matters? In Proceedings of the ACM Conference on computer supported cooperative work . New York: ACM Press; 2011. 8. Cronin MA, Weingart LR. Representational gaps, information processing, and conflict in functionally diverse teams. Academy of Management Review 2007;32:761-73 9. Hall KL, Stokols D, Moser RP, Taylor BK, Thornquist MD, Nebeling LC, Ehret CC, Barnett MJ, McTiernan A, Berger NA, et al. The collaboration readiness of transdisciplinary research teams and centers findings from the National Cancer Institute's TREC Year-One evaluation study. Am.J.Prev.Med. 2008 Aug;35(2 Suppl):S161-S172. PMCID:PMC3292855 10. Okhuysen GA, Eisenhardt KM. Integrating knowledge in groups: How formal interventions enable flexibility. Organization Science 2002;13:370-86 11. Olson JS, Olson GM. Working Together Apart: Collaboration Over the Internet. San Rafael: Morgan and Claypool; 2014. 12. Stokols D, Hall KL, Vogel AL. Core characteristics, definitions, and strategies for success. In: Haire-Joshu D, McBride TD, editors. Transdisciplinary Public Health: Research methods and practice. San Francisco: Jossey-Bass Publishers; 2013. p. 3-30. 13. Salazar M, Lant T, Kane A. To join or not to join: an investigation of individual facilitators and inhibitors of medical faculty participation in interdisciplinary research teams. Clin.Transl.Sci. 2011 Aug;4(4):274-8 14. Nussbeck SY, Skrowny D, O'Donoghue S, Schulze TG, Helbing K. How to design biospecimen identifiers and integrate relevant functionalities into your biospecimen management system. Biopreserv.Biobank. 2014 Jun;12(3):199-205. PMCID:PMC4066232 15. Vaught JB, Henderson MK. Biological sample collection, processing, storage and information management. IARC.Sci.Publ. 2011;(163):23-42 References Cited Page 260